Trihormonal Regulation of Metabolic Homeostasis: Redesigning Therapy of Diabetes

DESCRIPTION (provided by applicant): Project Summary Type 1 diabetes (T1DM) is becoming an increasing problem for the VA as a result of the influx of younger veterans into the system. Insulin monotherapy has been the only treatment for T1DM since the discovery of insulin in 1922. We have reported that induction of hyperleptinemia in totally insulin deficient rodents completely reverses the clinical and laboratory manifestations of uncontrolled diabetes and restores otherwise moribund rodents to full health. We find that leptin recapitulates every desirable action of insulin and opposes its undesirable lipogenic and cholesterogenic actions. The glycemic variability with insulin treatment of T1DM results from the disparate insulin requirements of the various target tissues of the hormone, which cannot be met by a single concentration of peripherally injected insulin, together with the wide fluxes in fatty acids. Leptin, by suppressing both glucagon and fatty acids, can overcome both of these insulin defects. Now we wish to determine the mechanisms of these remarkable effects and begin translation of our findings to humans. It if works as effectively as in rodents, it should improve the quality of diabetic life through increased glycemic stability, fewer insulin injections, blood glucose sampling, and a reduction in lipogenesis and cholesterogenesis and their macrovascular diseases.